A novel approach to determine the value of ESAT-6 as an antigen in M. tuberculosis infection and vaccines

Project Summary/Abstract
Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb) remains a major global health problem, and the
only licensed vaccine, Bacille Calmette-Guérin (BCG), lacks sufficient efficacy to control the TB pandemic.
Therefore, development of effective TB vaccines is a high priority for controlling global TB. Since CD4 T cells are
known to be important for protective immunity to TB, they have been the focus of TB vaccine development.
Regardless of the mechanism, to be effective, vaccines must contain one or more antigens that can induce
protective immune responses; not all antigens possess this potential, and some antigens can induce detrimental
immune responses. Of ~4,000 Mtb proteins, ESAT-6 is among the most immunogenic, as it induces robust CD4
T cell responses in response to infection in multiple host species including humans, mice, and cattle.
Consequently, ESAT-6 has been assumed be a valuable vaccine antigen, and it is included in multiple TB
vaccines at various stages of development and testing. However, vaccines that contain ESAT-6 combined with
other antigens have only modest efficacy even in animal models, and T cell responses to ESAT-6 in Mtb-exposed
humans do not distinguish those with latent TB from those with active TB. These results are consistent with
ESAT-6 acting as a decoy antigen that does not induce protective immunity to Mtb, and that may even interfere
with optimal immunity. Determining if ESAT-6 serves a decoy antigen is important for vaccine design, since
vaccination might enhance a decoy effect and limit vaccine efficacy. However, understanding the protective value
of ESAT-6 and testing the decoy hypothesis have been impeded by the fact that ESAT-6 is also essential for Mtb
virulence. Since traditional approaches have not been able to dissociate the role of ESAT-6 as a T cell antigen
and its role in virulence, we took an innovative approach and generated transgenic mice whose CD4 T cells
selectively lack the ability to respond to ESAT-6. We developed a novel strategy to express the I-Ab CD4 T cell
epitope of ESAT-6 in the thymus so it is recognized as self during T cell development and causes deletion of
ESAT-6-responsive CD4 T cells. We generated the mice and confirmed that they do not develop CD4 T cell
responses to ESAT-6 during Mtb infection. With these (‘ESAT-6 tolerant’, or ‘6T’) mice, we can now determine
the value of ESAT-6 as a CD4 T cell antigen without perturbing the function of ESAT-6 as a cell autonomous
virulence determinant. In this project, we propose to determine whether CD4 T cell responses to ESAT-6 are
beneficial, detrimental, or neutral in Mtb infection; we will determine whether ESAT-6 is a decoy antigen that
alters recognition of other Mtb antigens; and we will test the hypothesis that ESAT-6 contributes to vaccine
efficacy through mechanisms other than by serving as a T cell immunogen. Our findings will be valuable for
guiding antigen selection in new TB vaccines and will either increase confidence that ESAT-6 is a valuable TB
vaccine antigen or provide evidence that alternative antigens should be prioritized. The ESAT-6-tolerant mice we
generated may also provide a new model for novel vaccine antigen discovery.

Public health relevance
Project Narrative To solve longstanding questions about a protein that serves dual purposes in the bacteria that cause tuberculosis, we designed and generated a unique strain of mice whose T cells don't recognize that protein. With these mice, we will be able to determine whether T cell recognition of that protein contributes beneficial or detrimental immune responses during infection. The unique knowledge we generate will be valuable in developing effective vaccines against tuberculosis.